Enabling Fully Automated Closed Loop Control in Type 1 Diabetes Through an Artificial Intelligence Meal Detection Algorithm and Pramlintide

Summary
People with type 1 diabetes (T1D) have autoimmune destruction of beta cells resulting in insufficient insulin to
maintain normal glucose levels, thereby requiring exogenous insulin treatment, typically delivered
subcutaneously either continuously infused through an insulin pump or by injection multiple times throughout
the day. There are now commercial closed loop systems available that enable automated delivery of fast-
acting insulin in response to wireless continuous glucose monitoring (CGM) sensors that inform an automated
control algorithm to calculate and deliver insulin via a pump. Unfortunately, current commercial closed loop
systems are hybrid systems that require users to announce meals to the system, and these hybrid systems do
not control glucose well following meals. People oftentimes forget to announce their meals or misestimate their
carbohydrate intake, thereby leading to poor overall postprandial glucose control. The primary benefit of hybrid
closed loop systems has been during the overnight period when meals are not consumed. In a normal working
beta cell, the hormone amylin is co-secreted with insulin in response to meals to help suppress glucagon
production and delay gastric emptying, thereby reducing postprandial glucose increases. Pramlintide is an
analog of the endogenous hormone amylin. Our commercial partner, Adocia, has developed a coformulation of
insulin and pramlintide. In this project, we will develop a dual hormone (insulin and pramlintide), fully
automated closed loop system with a meal detection algorithm that will enable substantial improvements in
postprandial glycemic control for people with T1D while minimizing patient burden by not requiring a meal
announcement to the system. Our group has previously developed a multi hormone closed loop system
(insulin and glucagon) and we have developed models of insulin, pramlintide, glucagon, and carbohydrate
kinetics and dynamics that will be integrated into a new insulin+pramlintide closed loop model predictive
control (MPC) system (Aim 1). We have also developed a meal detection algorithm that will be integrated with
this MPC control algorithm to dose insulin and pramlintide shortly after a meal is detected, thereby eliminating
the need for the user to announce this meal to the system (Aim 1). We will use our in silico simulator of glucose
metabolism to identify the optimal dosing amount and timing when insulin and pramlintide are delivered in
response to the meal detection algorithm (Aim 1). Next, we will evaluate the optimal insulin and pramlintide
dosing therapies identified in Aim 1 and evaluate the top 4 strategies during an in-clinic meal test in a 4-arm
randomized crossover study in 14 people with T1D (Study 1a, Aim 2). We will then evaluate the optimal insulin
and pramlintide dosing therapy identified in Study 1a and compare with various insulin-only hybrid and
automated therapies in an in-clinic randomized crossover study (Study 1b, Aim2). Finally, in Aim 3, we will
evaluate the optimal insulin and pramlintide dosing therapy determined in Aim 2 and compare it with the
Tandem Diabetes Control-IQ commercial hybrid closed loop system.

Public health relevance
Narrative People with type 1 diabetes have difficulty managing their glucose levels, especially during the daytime in response to carbohydrate intake; persistently elevated glucose levels can lead to dangerous, poor overall health outcomes including retinopathy, neuropathy, and nephropathy. We will develop a new dual hormone (insulin and pramlintide), fully automated closed loop system that can automatically detect meals and dose in response to these meals. By combining the slowed gastric emptying and suppression of endogenous glucose production that pramlintide provides with a meal detection algorithm, we expect to translate a fully automated closed loop system with minimal patient burden that can achieve substantial improvements in glycemic control both during the evening and during the day.